Defining mechanisms of immunotherapy resistance in head and neck squamous cell carcinomas

PROJECT SUMMARY/ABSTRACT PD1 checkpoint blockade with nivolumab or pembrolizumab has given new hope for poor prognosis recurrent/metastatic head and neck squamous cell carcinoma (HNSCC) patients, but response rates of only 15-20% highlight the need for continued investigation. In this application, we have assembled a multidisciplinary team to address tumor cell intrinsic and adaptive resistance programs that are a critical barrier to immunotherapy. Together, this targeted and discovery based approach coupled with human functional immunophenotyping aims to generate new translational approaches to improving response rates for HNSCC patients. The foundation of this proposal is based on supporting data showing robust preclinical modeling platforms that span the spectrum of clinical responses to anti-PD1 therapy including response, intrinsic and adaptive resistance. Using high dimensional time of flight mass cytometry (CyTOF) and an isogenic model of response and resistance, we identified distinct tumor microenvironmental remodeling with anti-PD1 and anti- CTLA4 therapies. We also completed a genome scale CRISPR screen for T cell recognition in a PD1 resistant HNSCC model and identified 355 candidate genes that may regulate this interaction. Candidates included ones that may be relevant in all cancers as well as ones specific to HNSCCs. A major category to emerge from this and other screens represents targets in the chromatin accessibility pathway. We validated a top screen candidate that modulates chromatin accessibility, the histone methyltransferase and transcriptional regulator Ezh2, and identified reduced anti-PD-1 resistance in combination with Ezh2 targeting. These data illustrate the validity of our approach as well as potential for clinical translation, as agents targeting Ezh2 are currently in clinical development. In a separate study of immunotherapy treated HNSCC patients, we identified mutations in SMARCA4, a catalytic subunit key for the PBAF nucleosome remodeling complex, in immunotherapy responsive HNSCC patients, highlighting chromatin remodelers as modulators of immunotherapy response in patients and the potential for improved clinical management by targeting these activities in conjunction with immunotherapy. In the proposed work, we will complete analysis of Ezh2 targeting with further validation of candidate immunotherapy resistance modulators. Coupled with these preclinical studies we will complete functional immunophenotyping of human HNSCC patients using CyTOF and a novel patient derived organotypic platform. In parallel to these preclinical approaches, we have a strong clinical trial portfolio including a novel neoadjuvant pembrolizumab clinical trial that has shown surprising pathologic response in a subset of patients and highlights this approach as an ideal setting in which to address resistance mechanisms in previously untreated patients. We will interrogate genomic data from our neoadjuvant trial to assess resistance mechanisms defined in preclinical models. In conclusion, this integrated approach will define mechanistic and therapeutic approaches to address the intrinsic immunotherapy resistance in HNSCC.

Public health relevance
PROJECT NARRATIVE Tumor cell intrinsic resistance is a major barrier preventing many head and neck squamous cell carcinoma (HNSCC) patients from benefiting from FDA-approved anti-PD1 immunotherapeutics. Our supporting data in HNSCC preclinical models affirm the existence of diverse intrinsic immunotherapy resistance mechanisms, some of which are likely specific to HNSCC. Herein, we propose integrated functional and correlative studies of high fidelity preclinical models and patient tumors to define intrinsic resistance barriers to HNSCC immunotherapy and to delineate new therapeutic approaches.